Acute Inhibition of TAK1 as a Means to Control COVID-19 Pulmonary Hyperinflammation

PROJECT SUMMARY/ABSTRACT
The recent pandemic of novel coronavirus, COVID-19, has had a devastating effect on the health and well-being
of individuals across the globe, including over 3.1 million confirmed infected so far, and a monumental impact
on global healthcare systems and economies at large. In the US, over 1,000,000 cases have been confirmed to
date, including over 60,000 deaths, and some studies estimate that COVID-19 could cost the US healthcare
system $556 billion over the next two years. There are currently no approved treatments for COVID-19, and
many current efforts are expectedly targeting the viral mechanisms of disease. However, evidence from COVID-
19 patients has identified hyperinflammation as a major contributor to disease progression and outcomes, and
reduction of hyperinflammatory mediators such as TNF, IL-1 and IL-6 has become a novel therapeutic axis for
the treatment of COVID-19 patients. Thus, various branded anti-cytokine immunomodulators (e.g., anti-IL-1 and
anti-IL-6 biologics) are currently undergoing clinical trials to treat complications of COVID-19 disease such as
acute respiratory distress syndrome (ARDS), cytokine release syndrome, and pneumonia. However, all of these
therapeutics remove all target cytokine expression, dampening immune-viral detection leading to disease
progression. Therefore, there exists an unmet need for an orally bioavailable small molecule therapeutic that can
taper inflammatory cytokines to normal levels in an active COVID-19 infection. Our preclinical work has identified
TGFβ-activated kinase 1 (TAK1), as a key signaling element within the TNF-mediated proinflammatory response
pathway. Given recent clinical data identifying TNF as the primary player in the initiation of the COVID-19 induced
cytokine storm, we posit that TAK1 can be targeted to prevent or greatly reduce pulmonary hyperinflammation
seen in COVID-19 patients. Our recent discovery of the takinib scaffold and subsequent medicinal chemistry
efforts have led to the development of the first orally bioavailable, highly selective and potent (IC50 ~2.5nM)
inhibitor of TAK1, HS-276. To obtain proof-of-concept for development of TAK1 as target for COVID-19 induced
ARDS, we propose the following Specific Aims: Aim 1 – Establish the therapeutic efficacy of HS-276 to reduce
inflammation in the LPS-induced pulmonary inflammatory model. Milestone: Define the therapeutic window of
HS-276 in the LPS-induced pulmonary inflammatory model. Aim 2 – Evaluate the in vitro and in vivo effects of
TAK1 inhibition with HS-276 in response to COVID-19 spike protein (S-protein) challenge. Milestone: Establish
that HS-276 blocks S-protein induced TNF expression by ≥50% compared to vehicle-treated in vitro. Aim 3 –
Determine the efficacy of HS-276 to reduce viral-induced ARDS in a SARS-CoV-2 model. Milestone: Expand
preclinical indication/efficacy data of HS-276 to treat viral induced pulmonary hyperinflammation. Achieving the
Specific Aims above will provide the necessary data for us to pursue a Phase II NIH SBIR application to fund
pre-IND-enabling studies en route to IND-enabling studies.

Public health relevance
PROJECT NARRATIVE Development of an orally bioavailable and selective inhibitor of the inflammatory protein kinase TAK1 should have a major impact on COVID-19 treatment strategies by expanding beyond direct antiviral approaches to target the various inflammatory-driven pulmonary complications of the disease. Anti-cytokine immunomodulators (e.g., anti-IL-6, anti-IL-1 and JAK inhibitors) currently in clinical trials for COVID-19 highlight the growing evidence of potential therapeutic benefit of targeting pulmonary hyperinflammation, however these interventions completely ablate target cytokine signaling either through complete cytokine sequestration or broad anti- inflammatory effects, potentially leading to unchecked viral progression in the absence of a functional immune system. Thus, providing the COVID-19 treatment market with selective small molecule inhibitors which discretely target a single fundamental cytokine (such as through the TNF-TAK1 signaling pathway) may provide a safe and effective mechanism to control aberrant inflammation while retaining critical immune-viral detection, significantly improving the quality of care for COVID-19 patients in the US and across the globe.